NBER Coordinating Center on the Economics of AD/ADRD Prevention, Treatment, and Care.

OTHER PROJECT INFORMATION – Project Summary/Abstract
NBER Coordinating Center on the Economics of AD/ADRD Prevention, Treatment, and Care
This application proposes to establish a coordinating center for economic research on Alzheimer's disease (AD)
and AD-related dementia (ADRD) at the National Bureau of Economic Research (NBER). The consortium will
encompass the 4-5 research project (R01) grants that are awarded under the NIA's companion program
announcement on “Consortium for Economic Research on AD/ADRD Prevention, Treatment, and Care;” newly
funded Center studies selected annually from a national competition and supported under the Center's research
project core; the work of early career scholars selected for the Center's mentored scholars program; the NBER's
ongoing and separately-funded projects on the economics of ADRD; and selected other research on ADRD that
may be developed in the future. The underlying research projects that will be coordinated through the NBER
Center will be organized, at least initially, around four overarching themes: (1) Emerging Challenges in
Caregiving for People with ADRD, (2) Understanding ADRD Diagnosis and Progression, (3) Prevention and
Treatment of ADRD, and (4) Disparities in Healthcare for Patients with ADRD. In cooperation with NIA, we will
foster collaboration and synergies across consortium member research projects, initiate new high-impact
research projects that apply economic methods to understanding and improving the treatment and care for
people with ADRD; expand the network of researchers studying the economics of ADRD; and disseminate
findings to key stakeholders to support policymaking. An administrative core will provide intellectual leadership
and governance; centralized administrative, communications, and research support; support of early career
investigators; and ongoing monitoring of performance metrics though a program tracking plan. A research
projects core will support cutting edge research projects on the economics of ADRD prevention, treatment, and
care. A stakeholder engagement core will assure that the research projects are informed by the on the ground
experience of those working to prevent, treat and care for people living with ADRD and their families and
caregivers. A closely related translation core will encourage the application of findings from consortium research
in practical uses that improve the health and wellbeing of people living with AD/ADRD and their families;
disseminating findings and research resources, and convening an annual conference in Washington, DC.

Public health relevance
OTHER PROJECT INFORMATION – Project Narrative NBER Coordinating Center on the Economics of AD/ADRD Prevention, Treatment, and Care There are many public health reasons for a coordinated research consortium on the economics of Alzheimer’s disease and Alzheimer’s related dementias. First, the rising prevalence of ADRD with an aging population represents a profound and emergent challenge to our health and long-term care systems. Second, we are poised for a dramatic acceleration in our understanding of how to prevent and treat ADRD. Third, there are unique aspects, potential barriers, and disparities in how healthcare systems provide healthcare to people with ADRD.